Multimodal Dynamics of Parent-child Interactions and Suicide Risk

Suicide continues to be a growing public health concern. Indeed, suicide rates have increased 33% since
1999. This concern has been particularly pronounced in the case of adolescents, as the suicide rates in this
age group have tripled over the last 10 years. Clarifying potential processes of risk for suicidal behavior in this
population therefore remains a pressing priority. Increasing theoretical and empirical focus has been devoted
to the conceptualization of acute suicidal risk as being a period of elevated arousal. Stress within parent-child
relationship dynamics may hold particular importance for understanding adolescents' proximal risk for suicidal
behavior. However, all past studies examining parent-child relationship stress and suicidal behavior have used
self-report methodologies and/or retrospective recall. Although studies employing these methodologies provide
important knowledge about the association between life stress and mental health outcomes, they are not
designed to characterize the interpersonal dynamics of these stressors as they unfold over time, which may be
particularly relevant to short-term suicide risk. Recent advances in computational approaches to automatic
sensing of acoustic and visual behaviors hold promise to address the need for clarifying indices of arousal in
parent-child dynamics associated with adolescent suicide risk. A novel method to assess familial stress
processes is through the automated assessment of synchrony, or the behavioral matching, of arousal between
adolescents and their parents. In healthy parent-child dyads, parents and adolescents are responsive to each
other's behavioral and emotional cues. However, during high stress or conflict, behavioral matching may be a
marker of a high-risk interaction pattern inasmuch as it may be indicative of high arousal maintenance or
escalation. Focusing on the RDoC constructs of arousal and social processes, the current R21 proposal aims
to leverage recent developments in automated sensing of acoustic and visual behavior to characterize
synchrony within the dynamics of a parent-child conflict task in a sample of psychiatrically hospitalized
adolescents (n = 100) and their parents. The current study aims to evaluate whether acoustic and visual
behavioral markers of arousal synchrony, respectively, are associated with prospective suicidal ideation three
months post-discharge. We also aim to pool acoustic and visual behavioral markers of parent-child arousal
synchrony through computational modeling to create a multimodal prediction model for prospective suicidal
ideation, thereby to advance beyond unimodal analysis to multimodal analysis in classifying suicide risk. This
R21 is intended as an initial step toward automating the assessment of parent-child arousal synchrony within
clinical contexts to inform clinical decision-making and interventions. This proposal has both scientific and
clinical significance because it is the first study to employ computational automation of acoustic and visual
markers of suicide risk at the dyadic level and has the potential directly to inform adolescent suicide risk
assessment and intervention.

Public health relevance
PROJECT NARRATIVE This application aims to examine the dynamics of parent-child stress using automatic sensing of acoustic and visual behaviors as markers of suicide risk in adolescents. This proposal has both scientific and clinical significance because it is the first study to employ computational automation of acoustic and visual markers of suicide risk at the dyadic level. This research has the potential to improve our identification of stress-related risk in suicidal adolescents in periods of high risk and to directly inform clinical decision-making and intervention in the context of adolescents' psychiatric hospitalization.